Testing a mechanistic model for the storage and recall of an auditory memory underlying sensorimotor vocal learning

PROJECT SUMMARY: The ability to imitate others is a hallmark of human cognition and culture,
and underlie many aspects of our remarkable ability for thought and language. Songbirds have
been established as a powerful model system through decades of research, allowing for a
mechanistic understanding of how neural circuit dynamics control the learning and production of
complex sequential behaviors. Songbirds acquire their songs through an imitation process
reminiscent of human speech acquisition using a well-delineated set of brain regions. By listening
to their parents (or tutor sing), young birds form an auditory memory—a template. By comparing
their own highly variable babbling vocalizations to this template, young birds gradually refine their
own song using a trial-and-error reinforcement learning mechanism that requires a dopaminergic
performance signal. Songbird vocal imitations can have remarkable fidelity, often matching the
tutor song with striking acoustic and temporal precision. How is this template memory stored, in
particular the temporal structure? How is the template compared to the ongoing babbling
vocalization? And how does the auditory circuit form an error signal? In our previous work, we
found that the timing of song production is controlled by sequential neural dynamics within a
premotor region known as HVC. HVC has also been hypothesized to play a role in the formation
of the auditory memory used for imitation. This proposal aims to link these two functions within a
single framework. We hypothesize that, akin to its role during song production, HVC acts as a
clock during tutoring, forming a temporally precise memory of the tutor song that is actively
recalled during motor production to guide learning. In preliminary experiments, we have found
that thermal cooling of HVC during tutoring causes birds to subsequently develop songs that are
faster than their tutor (Aim 1). Furthermore, preliminary experiments show that tutoring produces
sequential patterns of neural activity in HVC, which we hypothesize are stored as dynamic
sequential ensembles that form the ‘clock’ of the tutor memory (Aim 2). HVC also projects back
to the auditory cortex, and we hypothesize that this projection transmits a copy of sparse
sequential activity that serves to predictively cancel the auditory signal at each moment in the
sequential ensemble. Preliminary experiments have revealed the song-specific adaptation and
error responses predicted by this model (Aim 3).

Public health relevance
Public Health Relevance: We are working to understand, at a detailed mechanistic level, how brain circuits learn to produce complex motor behaviors based on an internal evaluation of motor performance. This process involves cortical, thalamic, and basal ganglia circuits with a remarkable degree of homology to related motor control circuits in mammals. Given the shared design principles of avian and mammalian forebrain circuitry, such an understanding could have profound implications for identifying underlying causes, at the circuit level, of human developmental disorders in both motor and cognitive domains.